Altered Lymphatic Function and Development in Congenital Heart Disease

PROJECT SUMMARY / ABSTRACT
Aberrations in lymphatic structure and function are increasingly recognized as a significant source of morbidity
in a variety of disease states. For example, lymphatic abnormalities associated with congenital heart disease
(CHD) that result in increased pulmonary blood flow (PBF) include congenital or acquired chylothoraces, and
immunologic aberrations. Importantly, it is increasingly appreciated that lymphatic abnormalities are not only
associated with a variety of pulmonary diseases but participate in their pathogenesis. Recent recognition that
abnormal respiratory dysfunction often persists years after cardiac correction and is an independent risk factor
for mortality in adult CHD patients has brought renewed urgency to better understand the underlying lymphatic
pathobiology in CHD, which thus far remains largely unknown. We have previously used a clinically relevant
large animal model of CHD with increased PBF (shunt) in combination with isolated vessel reactivity of the
thoracic duct and primary lymphatic endothelial cell (LEC) culture, to demonstrate that chronically increased PBF
and the consequential increase in lymphatic flow, is associated with: 1) abnormal pulmonary lymphatic flow and
architecture; 2) increased mitochondrial reactive oxygen species (mtROS)-driven hypoxia inducible factor-1
(HIF-1) activity and metabolic reprograming to support cellular and proliferation; and 3) a KLF2-dependent
decrease in nitric oxide (NO) signaling. In this renewal application we will test our novel hypothesis that in the
setting of increased PBF, the mechanosensory channel Piezo1 plays a pivotal role sensing alterations in
lymphatic flow, triggering downstream increases in endothelin-1 (ET-1) and mtROS driven HIF-1a activity. This
results in decreased NO bioavailability and subsequent lymphatic dysfunction, that contributes to persistently
abnormal respiratory mechanics even after the cardiac defect has been repaired. In support of this hypothesis,
we present preliminary evidence demonstrating: 1) increased lymphatic endothelial Piezo1, ET-1, RhoA, and
mtROS in shunt LECs; 2) Piezo1-, ET-1-, and mtROS-dependent increases in HIF-1 in control LECs; 3) shunt
lambs have abnormal respiratory mechanics and lymphatic endothelial dysfunction that persists following closure
of the shunt, despite normalized hemodynamics, and 4) that treatment with a mitochondrially-targeted antioxidant
(mitoquinone, MitoQ) reverses the HIF-1 mediated shunt LEC phenotype in vitro and normalizes pulmonary
lymphatic architecture and function in vivo. This overall hypothesis will be tested in three inter-related, but
independent mechanistic aims, that utilize integrated physiologic, cellular, and molecular experiments. These
translational and targetable studies include: 1) whole animal hemodynamic physiologic studies, advanced
CT/MR imaging, and sophisticated pulmonary function testing, 2) ex vivo thoracic duct reactivity studies, and 3)
transcriptional and metabolic studies in LECs. A deeper understanding of the mechanisms investigated may lead
to improved treatment and prevention strategies for lymphatic abnormalities in the setting of CHD and other
disease states, including pneumonectomy and other vascular abnormalities that result in increased PBF.

Public health relevance
PROJECT NARRATIVE It is increasingly appreciated that aberrations in lymphatic structure and function participate in the pathogenesis of a variety of pulmonary diseases including the abnormal respiratory mechanics of children with common congenital heart disease (CHD) associated with increased pulmonary blood flow (PBF). In this proposal we will comprehensively elucidate the role of the altered lymphatic mechanical forces and subsequent HIF-1 stabilization in the pathobiology of lymphatic dysfunction in this setting, and the potential therapeutic targets that may restore lymphatic function. The data from these integrated in vitro and in vivo studies may easily translate into novel treatment and prevention strategies for lymphatic abnormalities in the setting of CHD and other disease states, including pneumonectomy and other vascular abnormalities that result in increased PBF.